MONOCLONAL ANTIBODY FACILITY

PROJECT SUMMARY (See instructions): Monoclonal Antibody Facility -MAF The Monoclonal Antibody (MAb) Facility (MAF) provides non-commercially-available antibodies to MD Anderson Cancer Center investigators for specific applications. The MAF serves basic, translational and clinical researchers across the institution and is currently developing projects in each of these three areas. Although the services are based on

Public health relevance
RELEVANCE (See instructions): The MAF develops high-quality, cost-effective customized MAbs to meet the basic, translational, and clinical research needs of MD Anderson investigators. Rates are comparable to other institutions across the country and, in some cases, significantly lower. Many of the MAbs generated have been licensed or patented.